Targeting Serine Auxotrophy in Luminal Breast Cancer

PROJECT SUMMARY/ABSTRACT
A major challenge of targeting metabolism for cancer therapy is pathway redundancy, where multiple
sources of critical nutrients can diminish the effects of metabolic therapies. An example of this can be found in
recent attempts to target the serine synthesis pathway for cancer therapy, where the abundance of serine
available to be taken up from the circulation has hampered the success of inhibitors of serine biosynthesis. This
places a premium on pursuing strategies of limiting pathway redundancy if we wish to successfully target serine
and other critical metabolic pathways for cancer therapy. We have taken the approach of analyzing human tumor
gene expression data to identify scenarios where pathway redundancy is limited due to lineage-dependent gene
expression, thereby creating potential vulnerabilities. Using this approach, we have found that the two major
lineages of breast tumors—luminal and basal—express vastly different levels of PSAT1 (phosphoserine
aminotransferase 1), the gene encoding the second enzyme of the serine synthesis pathway. Luminal breast
cancer cells, which express extremely low levels of PSAT1, are unable to activate the serine synthesis pathway
even when extracellular serine is completely absent. As a result, they are entirely dependent on exogenous
serine for proliferation and survival. This is in contrast to basal breast cancer cells, which are able to synthesize
serine and proliferate in the absence of extracellular serine. Mechanistically, this serine auxotrophy appears to
be due to luminal-specific methylation of the PSAT1 gene. Based on this data, we have developed the hypothesis
that lineage-specific epigenetic silencing of the PSAT1 gene induces serine auxotrophy in luminal breast tumors
and makes them vulnerable to inhibition of serine uptake. In this proposal, we will 1) determine whether luminal
breast tumors are sensitive to dietary serine starvation in vivo, 2) define the mechanism of PSAT1 suppression
in luminal tumors, and 3) identify and characterize serine transporters as potential pharmacological targets of
this vulnerability. While luminal breast cancer patients initially have a favorable prognosis due to the utility of
endocrine therapies, over half of all patients eventually develop resistance to these therapies and undergo
relapse. As a result, over half of all breast cancer fatalities are due to luminal breast cancer, making this an area
of significant unmet clinical need. The experiments described in this proposal have the potential to identify new
therapeutic options for patients with advanced luminal breast cancer.

Public health relevance
PROJECT NARRATIVE The unique metabolic phenotypes found in tumors offer many promising targets for cancer therapy, but pathway redundancy has emerged as a major challenge to successfully targeting many of the most important metabolic pathways. We have found that luminal breast tumors cannot synthesize the non-essential amino acid serine due to epigenetic suppression of the gene encoding PSAT1, an enzyme in the serine synthesis pathway. In this proposal, we will determine whether this makes luminal breast tumors sensitive to inhibition of serine uptake in vivo, which may represent a new target for treatment of advanced luminal breast cancer patients.